Metastatic Spine Tumors: Minimally Invasive Fracture Risk Analysis and Treatment - Master

Project Summary/Abstract
The identification of cancer metastases to the bony vertebral column obligates the treating clinician to make a
surgical decision. Current spinal stability decision-making is empirical, qualitative, and can be inaccurate. The
consequences of that decision for the patient, however, are significant. If the spine is deemed at risk for
fracture, then the patient will undergo a major spinal operation. Conversely, the patient whose spine is deemed
stable risks fracture and possible paralysis if the analysis was incorrect. This research program addresses both
the stability decision and the nature of the treatment. In this renewal application, we will continue our efforts to
develop non-invasive, quantitative, and reliable methods to predict the fracture risk of vertebrae with metastatic
cancer under physiologically relevant loading conditions, and to optimize minimally invasive techniques using
novel biomaterials to reconstitute the load bearing capacity of an affected vertebra. In Aim 1, we propose a
novel injectable polymer network that can be self-crosslinked via catalyst-free click chemistry into “click”
organic-inorganic nanohybrid (click-ON) bone cement. Compared to our previous injectable system, the novel
cement has improved biocompatibility, injectability, and crosslinking efficiency. In Aim 2, we will investigate the
efficacy of the optimized click-ON bone cement to both prevent impending fractures and treat existing fractures
in cadaveric models using the clinical vertebroplasty and kyphoplasty procedures, respectively (Aim 2a). Intact
lumbar spines (L1-S1), spines with simulated lytic defects, and spines with biomaterial augmentation will be
tested under accurate and biomimetic loading conditions using a novel robotic testing system. Our previously
developed quantitative computerized tomography based finite element analysis (QCT/FEA) models will be
expanded to include both kinematic motion evaluation and fracture risk prediction under physiological loading
and boundary conditions and validated using the experimental results (Aim 2b). In Aim 3, We will develop a
phantom-less calibration technique to account for the effects of QCT protocols on QCT/FEA results (Aim 3a).
Using the powerful AnalyzeMD platform, we will implement an automated process to further advance the FEA
technique for time efficiency and reproducibility (Aim 3b). We will apply the comprehensive QCT/FEA models
in a retrospective cohort of spine metastasis patients and assess the virtual reconstruction using the click-ON
bone cement as a first step towards clinical translation. The QCT/FEA technique developed in this work takes
into consideration both the quality and quantity of bone and the degeneration status of the intervertebral discs.
This technique allows the clinician to counsel her/his patient regarding activities of daily living that can be
performed with a low risk of spinal fracture. Our future plans are to expand the clinical implementation of the
spinal FEA analysis at Mayo Clinic. We will add FEA evaluation results in our discussion with the patients
regarding our recommendations for their care. We will study the outcome results of those recommendations,
adjust the decision parameters as necessary, and then extend the analysis to additional institutions.

Public health relevance
Project Narrative The computerized spinal stability assessment, for patients who have cancer that has spread to their spine, will offer more accurate prediction of the need for spine surgery to the patients, and with a much greater likelihood that the patients and their families can get the evaluation done promptly near their home, saving them time, expense, and inconvenience. The recommendation for non-surgical treatment will be made with increased assurance that the risk of a spine fracture is low, and the analysis methods will provide additional guidance on allowable, safe levels of their activities of daily living, which typically stratify out to household ambulation, community ambulation, and various levels of exercise and load bearing activities (e.g., carrying grandchildren, groceries, laundry, yard work). Those patients, who do need surgery, will be offered minimally invasive surgical techniques that will shorten their hospital stay and recovery time, and allow them to return home to their families sooner.